Identification of enteric nerve circuits controlling gut motility

Project Summary
The enteric nervous system (ENS) is a semi-autonomous division of the autonomic nervous system. The ENS
controls gastrointestinal motor function, absorption and secretion of nutrients and water and gut sensation. The
nerve circuits controlling these important functions are incompletely mapped. In specific aim 1, we will use an
antibody against the vesicular nucleotide transporter (VNUT), a protein marker for purinergic nerves to identify
these pathways. Purinergic neurotransmission is important in the ENS but there are no data describing the
purinergic neurons or pathways in the ENS. These will be important new data that will broaden our knowledge
of enteric synaptic connectivity. In specific aim 2 we will use cre-lox technology and adeno-associated virus
(AAV9) transduction of myenteric neurons to express the light-activated ion channel, channel rhodopsin-2
(ChR2) in specific neuronal subtypes. This will allow selective activation of specific functional classes of neurons
(interneurons, motorneurons, sensory neurons) to determine their specific synaptic connections and the
neurotransmitters that these neurons release. These studies will be done in mice and guinea pigs. We will use
cre driver mice where cre is driven by neuron-subtype specific promoter (choline acetyltransferase, purines, nitric
oxide synthase, 5-HT, for example) crossed with mice containing the floxed gene encoding ChR2. We will
measure excitatory and inhibitory junction potentials (EJPs, IJPs) using microelectrode electrophysiology
techniques to determine the neurochemical phenotype of neurons synapsing with excitatory and inhibitory
motorneurons supplying the longitudinal and circular muscle layers. In specific aim 3, we will also use the cre-
lox approach to study synaptic connections in myenteric ganglia. We will also use electrochemical methods to
measure local release of ATP and nitric oxide (NO) from myenteric neurons. We will optically stimulate individual
ganglia and make intracellular recordings from myenteric neurons on the oral and anal sides of the site of
stimulation. We will use microelectrodes filled with neurobiotin so the recorded neurons can be identified in
subsequent immunohistochemical studies to identify the neurochemical phenotype of neurons receiving synaptic
input from the optically stimulated neurons. These studies will identify synaptic connections responsible for
periodic propulsive colonic contractions. Successful completion of these studies will identify synaptic
connections between neurochemically identified subsets of myenteric neurons. These connections control
coordinated contractions and relaxation of gut smooth muscle leading to propulsion of gut content. A more
complete understanding of these pathways will aid in identifying deficits in neural control of gut motility and
identification of new drug or genetic treatments of gut motility disorders.

Public health relevance
Project Narrative This project will map functional nerve circuits in the enteric nervous system which controls gastrointestinal (GI) motility. Gastrointestinal motility disorders can be disabling. A thorough understanding of nervous system control of gut motility will help to develop new and effective treatments for GI motility disorders.